RFA-CK-22-003, Emerging Infections Sentinel Networks (EISN) Research - 2022

Project Summary
In 1995, following the Institute of Medicine’s report, “Emerging Infections,” and in response to
the CDC’s strategic plan to enhance surveillance, EMERGEncy ID NET was
established. EMERGEncy ID NET's goal was to address the threat of emerging infectious
diseases by assessing disease prevalence, risk factors, and management practices for acute
presentations from the community among a diverse and underserved population of patients
presenting to US emergency departments (EDs). A CDC cooperative grant has funded the
network for the last 25 years. Due to the ability to prospectively collect clinical data and
specimens for on-site laboratory analysis 24/7 from acutely ill patients from the community,
EMERGEncy ID NET has been able to produce translational research that has impacted
physician practices and informed public health policy. The research network demonstrated its
capability to successfully address an urgent public health threat during the COVID-19 pandemic
by rapidly implementing 20-site and 16-site public health surveillance projects of ED patient
care-related infection risk and vaccine effectiveness among frontline health care personnel.
Numerous peer-reviewed publications have resulted from EMERGEncy ID NET research,
including in high-impact journals such as The New England Journal of Medicine, the Journal of
the American Medical Association, Clinical Infectious Diseases, Emerging Infectious Diseases,
and Annals of Emergency Medicine.
Aims of EMERGEncy ID NET for the next 5 years are to: 1) identify emerging infections
and risk factors for these conditions affecting US ED patients, including among underserved
groups; 2) leverage EMERGEncy ID NET’s findings to create new collaborations to develop and
improve diagnostic tests, treatments, and vaccines; and 3) disseminate results at national
medical conferences, in high-impact journals, and on infectious diseases, public health, and
emergency medicine social media outlets to inform treatment and public health policy, and
educate the public. Support of EMERGEncy ID NET for the next 5 years will ensure that the
network can continue to answer new questions about emerging infections and related areas of
high public health priority.

Public health relevance
Project Narrative The EMERGEncy ID NET program is a sentinel research network of 12 geographically-diverse, university-affiliated US hospital emergency departments (EDs), which was established in 1995 to address the threat of emerging infectious diseases. Over the past 25 years, the network has worked closely with CDC partners to conduct translational research of emerging infectious diseases with a goal of improving patient care, health outcomes, and infection prevention strategies.